Resolving the interaction network of cell surface receptors

PROJECT SUMMARY/ABSTRACT
Cell signaling is initiated at the plasma membrane (PM), but our understanding of the chemical interactions that
regulate membrane protein function is still incomplete. The overall theme of my research group is to resolve
functional, molecular interactions in the complex environment of the PM. These efforts produce fundamental
insights into structure-function relationships of cell surface receptors and provide a crucial link between structural
biology and cell signaling. My work is aimed at the two largest families of membrane proteins: receptor tyrosine
kinases (RTKs) and G protein-coupled receptors (GPCRs). Both of these protein families are heavily targeted in
disease. GPCRs are the targets of over 30% of all FDA approved drugs. RTK inhibitors are the most successful
targeted therapies in cancer treatment. RTK function is coupled to dimerization, but the degree of
heterodimerization between receptors has not been investigated in a systematic way with a quantitative, live cell
methodology. Our objective is to quantify these interactions in live cells and determine the effects of ligands and
the plasma membrane environment. Chemokine receptors are class A GPCRs that regulate cell movement like
migration and infiltration in a broad range of cell types. Consequently, they are important in diseases ranging
from asthma and arthritis to psoriasis and cancer. CXCR4, for example, is the target of an FDA approved
compound for mobilizing hematopoietic stem cells in cancer. Many studies have demonstrated that chemokine
receptors can assemble into homodimers and heterodimers that regulate cell signaling and can be targeted in
drug development. These dimerization interactions are non-covalent and thus dynamic in nature, although the
precise thermodynamic and kinetic principles governing the interactions are not yet resolved. Furthermore, the
prevalence and stability of putative dimeric complexes has only been well characterized for a small number of
receptors, leaving open many questions about the importance of dimerization for other chemokine receptors. My
lab will use an innovative approach called pulsed interleaved excitation fluorescence cross-correlation
spectroscopy (PIE-FCCS) to resolve and quantify membrane protein interactions in live cells. Our future research
plans are to: (1) Investigate how ligand binding and cellular environment affect the local network of RTK
interactions, (2) Resolve the role of heteromerization on chemokine receptor GPCRs, and (3) Develop a 3-color-
PIE-FCCS instrument to resolve competition in the local interaction network of membrane proteins in live cells.
The outcomes of this work will be a quantitative description of membrane protein interaction networks, which will
provide fundamental insight into cell signaling pathways involving these receptors. This insight will in turn create
new opportunities for drug development and translational research.

Public health relevance
PROJECT NARRATIVE Membrane proteins are targeted by the majority of FDA approved drugs. Interactions like dimerization affect the way these proteins function and respond to drug binding, but have not been fully characterized for many important drug targets. This project uses an advanced fluorescence spectroscopy to probe membrane protein interactions in cells to determine how dimerization alters membrane protein structure and function.